Advanced Immunobiology Traning Program for Surgeons

Project Summary/Abstract
This training grant application seeks continued funding for the Advanced Immunobiology Training Program
(AITP) in the Duke University Department of Surgery. We developed this program to provide aspiring academic
surgeons with a means of obtaining advanced immunobiological training. Our goal is to produce individuals who
understand the immune underpinnings of surgically relevant diseases and, in doing so, create surgeon-scientists
who view immune manipulation as an important adjunct to, and possible replacement for, the surgical
manipulation of tissues. The training program combines the substantial academic rigor of the Duke University
School of Medicine with the Duke Department of Surgery’s longstanding commitment to training the next
generation of surgical clinician-scientists. The program is co-directed by an academic surgeon and a basic
sciences researcher, each with formal expertise in immunology. It offers formal training with a diverse group of
20 mentors, each with expertise in basic, translational, and/or clinical aspects of immunology across a wide array
of applicable topics, including cancer biology, auto-, allo-, and xeno-immunity, vaccinology, and basic
mechanistic immunological pathways. This multidisciplinary team is uniquely qualified to merge basic and
applied immunobiology with evolving surgical practice. Program participants consist of postdoctoral trainees who
have completed medical school and have already entered surgical residency. At least six individuals will be
trained during the proposed funding period. Based on individual development plans, each trainee chooses to
participate in either a two-year training program, which can include coursework leading to a Master of Health
Sciences degree in Clinical Research, or a three-year training program including coursework in pursuit of a PhD
in Immunology. Trainees who already have their PhD in immunology are offered formal post-doctoral training
opportunities, which are often missing in the training of surgeon MD-PhDs. Guided by their mentors, trainees
have access to a structured didactic curriculum transitioning to a mentored research experience, as appropriate
for each trainee’s prior experience. A robust research infrastructure and substantial departmental resources
support the students, facilitating their conduct and publication of original investigations with complete protection
from clinical service. Specific instruction in technical aspects of immunological investigation is provided, as is
formal mentorship in scientific writing, publication, ethics, and clinical time management. Specific focus will
continue to attract a diverse group of trainees to this highly rigorous program, equipping a select group of
surgeons with a unique and highly contemporary skill set to approach surgical diseases.

Public health relevance
Project Narrative / Public Health Relevance Immunobiological research findings have become increasingly relevant in surgical practice, influencing diverse surgical disciplines including oncology, transplantation, trauma, and critical care. Although the importance of immune manipulation has become an evident adjunct to the practice of surgery, and a necessary component of most advances in surgical disease, surgical training neither includes advanced immunology nor prepares surgeon-scientists to participate in immune-related research. This program aims to provide surgeons with training in advanced immunology and create surgeon-scientists capable of participating and leading in surgically relevant areas of immunobiological research.